The WashU-UCSC-EBI Human Genome Reference Center."

PROJECT SUMMARY (PROJECT 2 SUPPLEMENT) The goal of the WashU-UCSC-EBI based Human Genome Reference Center (HGRC) is to maintain and update the new human genome reference produced by the Human Genome Reference Program (HGRP) and to provide it to the scientific community. The goal of the HGRP Outreach and Education Center (HGRP-OE) is to communication with the entire scientific and medical communities and disseminate data, resources, tools, protocols, and educational materials. In this supplement, we plan to significantly expand our outreach and education effort to form a strategic partnership between the Global Alliance for Genomics and Health (GA4GH) and the Human Pangenome Project (including the Human Pangenome Reference Consortium and international partnerships). We will establish, develop and coordinate the Global Pangenome Reference Community to assist in ensuring the (a) organization and communications needs for this community; (b) website development and maintenance; (c) integration with HPRC Coordination Center and GA4GH Community. If successfully implemented, our proposed expansion will greatly increase community awareness of the new human genome reference and its usage, and thus maximize its use, value, and significance; and will expand the use and application of tools to facilitate secure and responsible data-sharing, and further engage global and national projects in genomics and precision health.

Public health relevance
PROJECT NARRATIVE The human reference genome is a scientific data resource that is intended to be a standardized representation of our species' collective genome. It is crucial for human biomedical research because it is used by virtually all studies that incorporate genetic information. This project aims to update and improve the human reference genome by vastly expanding the number of individuals and human populations that are represented and creating the human pangenome reference. The supplement aims to facilitate establishment of an international community for building and disseminating the human pangenome reference.